A generative-AI-assisted platform for rapidly creating interactive,accurate 3D explainers for all of biomedical science and medicine (TABA Supplement)

Project Summary/Abstract
Our currently active NIH Phase I SBIR project focuses on the development of a human-vetted, AI-augmented
web platform that transforms complex scientific text into accurate, pedagogically sound visuals. With the rise of
large language models (LLMs) from providers like OpenAI, DeepSeek, and Anthropic, information access has
dramatically improved, but these tools remain text-dominant. Our product addresses the needs of the large
population of visual learners in STEM by generating curated graphics that enhance comprehension and retention.
To maintain a first-mover advantage, we now seek to supplement our core R&D effort with critical business and
technical intelligence services that will guide us through an increasingly complex competitive and regulatory
landscape—particularly as AI visualization tools become more relevant to healthcare and medical education.
This Technical and Business Assistance (TABA) supplement will fund third-party expert services and resources
that are outside the technical scope of our current Phase I award, but are essential for de-risking
commercialization. These activities include benchmarking emerging LLM and VLM models across multiple
providers (e.g., OpenAI, Google, DeepSeek) to identify cost-effective, high-performing platforms for integration,
and engaging HIPAA compliance and FDA regulatory consultants to ensure future readiness for healthcare
deployment. Since our initial application, the FDA has released new draft guidance on AI-enabled software
functions (FDA-2024-D-4488), signaling regulatory scrutiny of tools like ours when deployed in clinical workflows.
The proposed TABA work will directly accelerate the impact and reach of our Phase I innovation by informing
our model selection, compliance approach, and product roadmap. These activities will also position us to enter
healthcare and health education markets more responsibly and competitively. By leveraging third-party
assessments and regulatory strategy experts, we aim to ensure that our AI-enabled visualization system is not
only technically robust but also aligned with evolving standards in safety, privacy, and market expectations.

Public health relevance
Project Narrative This project supports the development of an AI-enabled web platform that transforms scientific text into high- quality, human-vetted visuals to improve STEM education and comprehension. By supplementing our current NIH SBIR Phase I award with Technical and Business Assistance (TABA) funds, we will benchmark the latest AI models for cost and performance, and work with third-party regulatory services to evaluate HIPAA compliance and FDA oversight implications. This will help us ensure that our product is well-positioned for responsible use in healthcare, education, and other regulated domains, ultimately improving access to accurate and engaging scientific communication tools.